Functional Mechanism of Neural Control in Post-Concussion Convergence Insufficiency

Project Summary/Abstract: During the past 6 years, our study team investigated the neural mechanism of
typically-occurring convergence insufficiency (TYP-CI), the most common binocular vision disorder in children
and young adults (3.4% to 12.7%5–11) leading to 20 publications12–31 with 4 more in review and 6 in preparation.
We conducted the only randomized clinical trial (RCT) integrating objective eye movement and fMRI outcome
measures, achieving 100% planned enrollment and retention of 100 young adults.28 Our results localized the
reduction in functional activity for TYP-CI compared to controls within the oculomotor vermis (OVM) and the
cuneus. Functional activity in the OVM and cuneus was significantly correlated to convergence peak velocity
providing the first mechanistic identification of these deficits that create significant burden to those afflicted. 23
Our longitudinal results discovered that the neural mechanistic change stimulated by office-based vergence
/accommodative therapy (OBVAT) is an increase in the frontal eye field (FEF) and thalamus functional activity.
Increased functional activity from the FEF and thalamus significantly correlates to convergence peak
velocity. 23,32,33
Results are leading to personalized point-of-care therapies remediating the debilitating
symptoms for TYP-CI patients. While our research and results of other RCTs show that OBVAT is the most
effective treatment for remediating symptoms and improving vision function in both TYP-CI children 34–36 and
adults, 37,38 none of these participants had a history of head injury, a pathology that has been linked to CI. Our
research team has demonstrated that the prevalence of CI is higher (38% to 49%) in children 39,40 and
adults 41,42 with persistent post-concussive symptoms (PPCS-CI), than in the non-concussed population.
Currently, there is no validated treatment for PPCS-CI. This difference in prevalence, mode of onset
(longstanding versus sudden onset), and severity of the condition has led to a debate about whether the
diagnostic and management procedures effective for TYP-CI should be utilized for PPCS-CI, and strongly
suggests that new research is needed to optimize PPCS-CI management. We are uniquely positioned to
provide answers to these questions by building on our work establishing the neurofunctional mechanism of
TYP-CI and OBVAT administered to TYP-CI. Such research is of great importance because PPCS-CI is
associated with debilitating visual symptoms impacting the return to school/sports, 43–47 work, 48–51 or driving. 52
We have identified three significant gaps for the treatment of PPCS-CI that must be addressed to determine its
most effective management. First, given the obvious differences in etiology, are there significant differences
between TYP-CI and PPCS-CI related to objective eye movement measures (peak velocity, final amplitude,
and repeatability) due to underlying neural mechanistic differences? Second, what is the underlying neural
mechanism of OBVAT for PPCS-CI compared to TYP-CI? Third, how effective is OBVAT for PPCS-CI and is
the dosage of administration different than TYP-CI? This renewal addresses these gaps in clinical science.

Public health relevance
Project Narrative: Our successful R01 discovered 1) the neural mechanistic difference between typically- occurring convergence insufficiency (TYP-CI) and binocularly normal controls and 2) the underlying mechanism of office-based vergence and accommodative therapy (OBVAT) that is effective in remediating symptoms. Adolescent and young adult concussion is considered a substantial health problem in the United States1–3 where our team has shown that about half of patients with persistent post-concussion symptoms have convergence insufficiency (PPCS-CI), 4 causing significant negative impact associated with reading or digital screen-related activities, and is believed to be one factor causing delayed recovery impacting return to school, sports, or work. The results of this randomized clinical trial will impact the lives of adolescents and young adults with PPCS-CI to guide professionals on how to manage and treat those with PPCS-CI by 1) comparing the differences between PPCS-CI and TYP-CI, 2) discovering the neural mechanism of OBVAT for PPCS-CI compared to standard-community concussion care, and 3) determining the effectiveness of 12 one- hour sessions compared to 16 one-hour sessions of OBVAT.